A Novel Therapeutic Approach to Treat Focal Segmental Glomerulosclerosis (FSGS)

FSGS is characterized by segmental scarring of the glomerulus and nephrotic syndrome. Despite current
therapies, ~50% of nephrotic patients progress to end stage kidney disease (ESKD) over a decade. As a result,
there is much interest in developing new treatments. FSGS is defined by its characteristic histologic pattern, but
the disease is caused by multiple, distinct etiologies, which share a final common pathway of podocyte injury
and depletion. Because podocytes are terminally differentiated, postmitotic cells, podocytes that are lost cannot
be effectively replaced, causing instability and collapse of the glomerular tuft, and disease progression.
Treatment is focused on preventing podocyte injury and loss. Accumulating evidence suggests that cGMP
signaling is podocyte protective in glomerular diseases. Natriuretic peptides (NPs) potently stimulate cGMP
generation in podocytes by binding to NP receptors (NPRs). NPRA binds atrial NP (ANP) and brain NP (BNP),
and NPRB binds the C-type NP (CNP). Podocyte specific knockout (KO) of the cGMP generating ANP/BNP
receptor, NPRA, augments glomerular injury in proteinuric mouse models, indicating that NPs have podocyte
protective actions. A negative regulator of NP actions is the clearance receptor NPRC, which binds and degrades
ANP, BNP and CNP. Our preliminary experiments found: 1. Podocytes express NPRA, NPRB and NPRC. 2.
NPs protect podocytes from apoptotic stimuli, 3. NPRC is highly expressed in podocytes and limits cGMP
generation by locally available NPs, 4. Pharmacologic blockade of NPRC potentiates NPRA- and NPRB-induced
cGMP generation in cultured podocytes and in vivo, and 5. Podocyte specific KO of NPRC reduces albuminuria
in a mouse model of FSGS. The decrease in albuminuria in podocyte specific NPRC KO mice is unlikely to be
mediated by systemic or hemodynamic mechanisms, and suggests a direct podocyte protective effect. Based
on these findings, we hypothesized that blocking clearance of NPs by NPRC will elevate NP levels and promote
podocyte protective cGMP signaling. Aim 1 will study the effect of podocyte specific KO of NPRC in 1. A mouse
model of FSGS created in our laboratory (model 1), and 2. The Adriamycin model of FSGS (model 2). Aim 2
exams pharmacologic blockade of NPRC in model 1 using a novel NPRC antagonist. Current NPRC ligands are
peptide analogs of ANP, which are rapidly degraded in the circulation. This novel ligand is resistant to
degradation and robustly enhances cGMP generation in vivo compared to currently available NPRC ligands.
The proposed studies address the goals of the funding opportunity by "performing proof of concept studies in an
animal model of a rare disease". These experiments will establish "proof of concept" and provide the
rationale for developing effective, degradation resistant inhibitors of NP clearance. Development of
these drugs will provide the basis for preclinical studies using pharmacologic inhibitors of NP clearance
to elevate NP levels and cGMP signaling in podocytes and, in turn, reduce glomerular injury in FSGS.

Public health relevance
RELEVANCE Diseases affecting the kidney’s filter are the most common cause of end stage kidney disease (ESKD) in the United States. The goal of the proposed studies is to determine if potentiating the effects of a hormonal system that protects the cells forming the kidney’s filter prevents or slows progression of these disease processes. If the treatment approach protects the kidneys filter from injury, the therapy might be developed to treat a large number of diseases that cause ESKD.